CORE A - Administrative Core

SUMMARY
Core A is the administrative core facility responsible for overall administration in support of the research aims
and goals of the program, and is further responsible for meeting all programmatic administrative requirements
of the multiple institutions involved. Core A will provide services that are essential for the completion of
research goals addressing the central hypothesis of the overall program: Protein glycosylation and glycoprotein
remodeling alter the coagulopathy and inflammation of sepsis. Core A provides administrative functions that
are needed by all of the projects, core facilities, and program-funded personnel. Core A will be the nexus of
programmatic communications among program participants including project leaders, core leaders, advisory
board members, collaborators and consultants, and laboratory and research personnel. The overall
administrative goal of Core A is to establish and maintain essential programmatic administrative functions in
the most efficient and optimal manner possible. In addition, Core A will continue to establish and maintain
effective inter-departmental and inter-institutional communications with multiple offices and staff as needed to
achieve the administrative duties required. The Core A administrative facility will maintain records of relevant
program activities in fulfilling the administrative requirements as detailed in the application. The administrative
functions of Core A include maintaining an effective office infrastructure with multiple routine modes of
communication, monitoring project and core expenditures, assistance with orientation and administration of
program personnel, execution and record keeping of relevant programmatic meetings and progress reports,
composing and maintaining program personnel communication lists, assistance to program personnel
regarding program publications and compositionand submission of program reporting, organization of meetings
of program investigators, staff, and advisory board members, and organization and execution of program
personnel off-site travel including annual program retreats. Core A will further operate in assistance with
project personnel as a liaison with Santa Barbara Cottage Hospital physicians and research office staff in
facilitating communications and documents transfers enabling accreditation regarding human subjects use with
Internal Review Board certification in support of the program. The structure and organization of Core A
includes a Core Leader and Program Assistant whom together will provide the administrative functions in
support of program project and core personnel and activities.